Chemoenzymatic Strategies for Molecular Discovery and Asymmetric Synthesis

Chemoenzymatic Strategies for Molecular Discovery and Asymmetric Synthesis
Building upon the progress made under prior NIGMS support, this MIRA project aims to introduce and pursue
innovative strategies and platforms for (a) driving the discovery of ‘natural product’-like macrocyclic peptides as
potent and selective modulators of biomolecular interactions, and (b) developing biocatalytic strategies for
asymmetric synthesis via ‘new-to-nature’ chemistries. Under R01 GM134076 support, we introduced efficient
and highly versatile methodologies for generating libraries of genetically encoded macrocyclic peptides in
bacterial cells or displayed on phage particles, and demonstrated the effectiveness of these 'natural product-like'
macrocycles toward disrupting biomedically relevant protein-protein interactions with high potency and
specificity. Building upon this progress, these methodologies and platforms will be further expanded and
potentiated through (i) the development of novel methods for the programmable synthesis of topologically
complex macrocyclic peptides, including polycyclic peptide scaffolds; (ii) their integration with chemical warheads
for the development of covalent protein inhibitors and (iii) the implementation of a new system for target-driven
discovery in complex intracellular environments. These systems will be validated and applied to the discovery of
cyclopeptide modulators of challenging biomolecular targets, including membrane proteins. Ultimately, these
technologies are expected to streamline both the development of chemical probes for interrogating cellular
pathways and validating therapeutic targets, and the discovery of potential lead structures for drug development,
thereby accelerating efforts in basic biomedical research, chemical biology, and drug discovery. Under
R01GM098628 support, we have pioneered and demonstrated the use of engineered myoglobins and other
hemoproteins as efficient and robust biocatalysts for stereoselective carbene transfer reactions. Building upon
this work, this research will investigate and extend the scope of these metalloprotein catalysts to a range of new,
asymmetric carbon-carbon and carbon-heteroatom bond forming transformations useful for the synthesis of
optically active building blocks and complex organic scaffolds of direct value for medicinal chemistry and drug
discovery. Computational design, mechanism-guided design, and high-throughput experimentation will be
leveraged to expedite the discovery and optimization of hemoprotein-based carbene transferases with enhanced
catalytic efficiency, expanded reactivity, and fine-tuned stereoselectivity. The synthetic value of these
methodologies will be further highlighted through the stereoselective, chemoenzymatic synthesis of drug
molecules and natural products. Overall, this research is expected to make available new methodologies for the
efficient, selective, and sustainable synthesis and diversification of biologically active molecules.

Public health relevance
Narrative This project will implement broadly useful chemoenzymatic methodologies and platforms for the synthesis and discovery of bioactive molecules. In one area, this project will develop novel biocatalytic systems for the preparation of optically active building blocks and molecules of direct value for medicinal chemistry and drug discovery campaigns. In a second area, this project will develop high- throughput platforms useful for the discovery and development of cyclic peptides capable of targeting and modulating the function of biomolecules with high activity and selectivity, thereby providing selective chemical agents useful for both basic biomedical research and drug discovery.